Adolescent Alcohol in 5xFAD Mouse Model Accelerates Neuroinflammation and Alzheimer's Disease Pathology Across Aging

ABSTRACT. Adolescent Alcohol in 5xFAD Mouse Model Accelerates Neuroinflammation and
Alzheimer’s Disease Pathology Across Aging. Our laboratory and others find adolescent intermittent ethanol
(AIE; 2-days EtOH/2-days NO EtOH during adolescence) primes and accelerates adult Alzheimer’s disease
(AD)-related degeneration and cognitive deficits that persist in the absence of continued adult EtOH exposure.
Our premise for this proposal is built on priming of common mechanisms of pathology, including chronic
neuroinflammation and loss of basal forebrain cholinergic neurons (BFCNs). This proposal will test the
overarching hypothesis that AIE-induced persistent, life-long loss of BFCNs and chronic
neuroinflammation contribute to the onset and progression of AD-associated neuropathology and
cognitive decline across aging. This hypothesis is built on our preliminary findings, including (1) AIE increase
of receptor for advanced glycation end-products (RAGE) and other neuroinflammatory molecules, induction of
AD-associated genes, and reductions of BFCNs, hippocampal neurogenesis, and cognitive function in
adulthood; (2) increased RAGE-neuroinflammation and AD-like pathology in post-mortem human AUD brain
samples of individuals with an adolescent age of drinking onset. We recently discovered that AIE accelerates
adult BFCN neurodegeneration, neuroinflammation, and accumulation of amyloid-β (Aβ) in a genetic mouse
model of AD. We developed an innovative mouse model using the 5xFAD genetic mouse model of AD, which
recapitulates the dual Aβ accumulation and neurodegeneration observed in human AD, crossbred with ChAT-
Cre mice to investigate interactions of AIE with Aβ accumulation across aging on BFCN and hippocampal
pathology. Aim 1 tests the hypothesis that AIE accelerates AD-associated neuropathology in the aging
brain of ChAT-Cre::5xFAD mice. We expect AIE will accelerate neuroinflammation, neurodegeneration, and
AD-associated pathology across ages. Aim 2 tests the hypothesis that AIE-induced basal forebrain RAGE-
neuroinflammatory signaling causes BFCN loss, neuroimmune signaling, AD pathology, and cholinergic
dysfunction in the aging brain of ChAT-Cre::5xFAD mice. AIE induces RAGE-neuroinflammatory signaling
and loss of BFCNs that persists into adulthood. We expect RAGE-neuroinflammatory signaling contributes to
AD-associated BFCN pathology. Aim 3 tests the hypothesis that chronic activation of basal forebrain
cholinergic activity during AIE prevents loss of hippocampal activity, neurogenesis, and cognitive
function, and reduces AD-associated neuropathology in the aging brain of ChAT-Cre::5xFAD mice. AIE
increases hippocampal neuroinflammation, reduces neurogenesis, and impairs cognition in adulthood that is
prevented by anti-cholinesterase drugs. We expect BFCN activation to both identify cholinergic involvement and
recover AD-associated hippocampal pathology. The proposed studies will link early life insults (i.e., adolescent
binge drinking) to AD-like neurodegeneration and dementia in the aging brain, and identify potential therapeutics.

Public health relevance
PROJECT NARRATIVE. Adolescent alcohol abuse causes progressive neurodegeneration that parallels Alzheimer’s disease-related pathology, including chronic neuroinflammation, persistent degeneration of basal forebrain cholinergic neurons, hippocampal neurodegeneration, and lasting cognitive deficits. The proposed studies will investigate adolescent alcohol abuse as a novel etiological factor priming and accelerating progression of basal forebrain and hippocampal neurodegeneration with age to Alzheimer’s disease. Prevention studies will link adolescent neuroinflammation and cholinergic degeneration to age-related neurodegeneration and cognitive deficits observed in human Alzheimer’s disease and provide new therapeutic targets.